Medication Development for the Treatment of Alcohol Use Disorder

PROJECT SUMMARY
Our application is in response to RFA-AA-20-007 [Medications Development for the Treatment of Alcohol Use
Disorder (AUD)]. Initial evidence supporting a neuroimmune hypothesis for excessive alcohol consumption led
us to test tetracyclines in reward- and dependence-models. Having shown reductions in drinking and acute
withdrawal, we used structure-functional data to design new chemically modified minocycline (CMM) compounds
for loss of antibiotic properties, but retention of known innate immune action. In collaboration with the NIAAA
Division of Medications Development, we have created and tested 16 CMM analogs for potential treatment of
AUD. Several have shown both a loss of antimicrobial action and improvement over minocycline to reduce
drinking in animal models of high alcohol consumption. Following oral administration tests, we have now
identified a lead (best choice) and a backup compound and are in the process of completing preclinical
pharmacology and toxicology screens. Nearly 15 million people in the US and ~100 million worldwide suffer
from AUD. Over 5% of all medical morbidities share an ethanol-related risk. Although there are three FDA
approved drugs to treat AUD, and several others are used off-label, medications have shown only modest
success (in ~20% of patients treated). As a consequence, there is an urgent need for new pharmacotherapeutics
across the DSM-V AUD spectrum. In fact, improved drugs that reduce high alcohol consumption in either reward-
or relief-seeking patients would be most desirable. Currently, gabapentin is used off label as such; it reduces
alcohol consumption and dependence-related symptoms, but its modest effectiveness and significant side-
effects leave opportunity for considerable improvement. As required by the FDA, preliminary data for our CMMs
show a significant reduction of alcohol consumption in two mammalian species. We have patents covering over
100 tetracycline modifications for use in neuroinflammatory diseases, including AUD. Texas Tech University
System holds the patent rights. They have been licensed to South Plains Biotechnology, Inc., AUD subdivision,
LLC, which is owned, in part, by researchers associated with this project. As a consequence, the success of the
below aims represent a positive step toward potential commercialization. We will complete four aims
addressing: Aim 1: Development of manufacturing standards; Aim 2: Completion of pre-clinical IND enabling
studies; Aim 3: Phase I clinical trial; single-ascending dose; Aim 4: Phase I clinical trial; multiple-ascending
dose. Future Phase II plans include testing in reward- and relief-seeking AUD patients, first in a small trial with
our Clinical Research Institute and then in cooperation with the NIAAA Clinical Investigations Group. Impact:
The development of a drug without addiction potential that successfully treats reward- and relief-driven
AUD is critically needed. Our NIAAA collaboration, TTUHSC team, scientific advisers (Drs. Adron Harris and
Bob Messing) and FastTrack (FDA consulting firm) represent unique expertise to complete the proposed work.

Public health relevance
Public Health Relevance Statement (Project Narrative) Alcohol Use Disorder is a complex spectrum disorder that presents significant unmet clinical treatment challenges. Accumulating evidence indicates that the action of ethanol on the innate immune system leads to chronification of risky drinking, potential physical dependence, and often dangerous withdrawal symptoms. The proposed project is a collaboration with NIAAA’s Division of Medications Development and addresses creation of manufacturing standards for two lead compounds and IND enabling studies for FDA approval for a Phase I clinical trial.